Inhibition of metastasis-initiating cells by chimeric polypeptide nanoparticles

Abstract Less than 10% of metastatic tumors are curable by current therapies, a fact that warrants the need for more effective strategies to treat these tumors. The overall goal of this project is to develop a nanoscale drug carrier system to improve therapy of cancer metastases. The applicant of this K99/R00 proposal recently designed a novel polypeptide drug carrier, chimeric polypeptides (CP), which self-assembles into nanoparticles upon drug conjugation, and which displays a long circulation half-life and good accumulation in tumors, as compared to free drug. The candidate hypothesizes that the invasive behaviors of metastasis-initiating cells (MICs) can be utilized for drug delivery using CP-based nanoparticles loaded with an anti-MIC drug, salinomycin (Sali) base on the following observations: (a) nanoscale drug carriers accumulate in the perivasuclar region of tumors; (b) MICs migrate through the perivascular space and invade a blood vessel as their first step in metastasis, and (c) MICs rely on potent peptidase activities in the local extracellular matrix (ECM) to degrade the ECM facilitate their migration. We will leverage these three facts to design a nanoscale delivery system that specifically targets MICs via a CP nanoparticle that is loaded with Sali. The overall hypothesis of this proposal will be tested by the following three aims: (1) Sali will be conjugated with a range of CPs with varied composition, physico-chemical properties and molecular weights to systematically vary the in vivo stability of the CP-Sali conjugate; (2) the attachment triggered self-assembly of the CP-Sali conjugates into sub-100 nm diameter particles and their in vivo stability will be quantified; (3) a peptide substrate of an invasion-associated proteinase, matrix metalloproteinase 2 (MMP2), will be incorporated into the primary amino acid sequence of the CP, and the resulting MMP2-dependent cleavage, cellular uptake, cytotoxicity, and the metastasis- inhibitory activity of CP(MMP2)-sali conjugates will be studied. The proposed drug carrier system will be the first to exploit the mobility of MICs for drug delivery, and the study may lead to a novel therapy for cancer metastases. The overall career goal of the candidate is to become an independent investigator contributing at the interface of nanotechnology and cancer therapy. This goal is backed by candidate's excellent prior training and research productivity. Through this career development award, the candidate will: (1) acquire additional training under the mentorship of Dr. Ashutosh Chilkoti and Dr. Mark W. Dewhirst, who are well-known investigators in nanotechnology and cancer therapy, respectively; (2) closely interact with his career advisory committee and accomplish career transition under the guidance of the committee; (3) produce research results, which serve not only as a foundation for him to apply for future federal funding on cancer nanotechnology. This research is relevant to public health because it will lead to an innovative therapeutic strategy for the treatment of cancer metastasis.

Public health relevance
Project Narrative This research project is relevant to public health because the achievements of this project will lead to innovation of a better therapeutic strategy to prevent tumor metastasis, and the knowledge generated is valuable for future development of the anti- metastasis therapy. The research project also provides training opportunity for future scientists in cancer nanotechnology research. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Less than 10% of metastatic tumors are curable by current therapies, making metastasis the major cause of cancer-related death and indicating the need for more effective strategies to treat metastasis. The overall objective of this research project is to develop a nanoscale drug carrier system that prevents blood vessel-dependent metastasis by exploiting the invasive behavior of metastasis-initiating cells (MICs). The rationale for this project is as follows: MICs need to migrate through the perivascular space and invade a blood vessel as their first step to establish metastasis. MICs rely on enzymes to degrade the extracellular matrix (ECM) to facilitate this migration through the perivascular space. Recently, several anti-MIC drugs have been identified including salinomycin (Sali), but to my knowledge there are not yet any rationally designed nanoscale carriers for this class of drugs that provide the necessary degree of intratumoral spatial localization and drug release to selectively inhibit MICs. Thus, this proposal will enable clinical application of anti-MIC drugs by rationally designing a nanoscale delivery system that addresses the delivery needs for this sub-class of tumor cells. Using our knowledge of MICs and recently identified small molecule MIC inhibitors, I will develop an invasion- responsive drug delivery system. This system is based on a novel nanoparticle drug carrier I helped to develop, termed chimeric polypeptide (CP), which self-assembles into nanoparticles upon drug conjugation, displaying a long circulation half-life and increasing accumulation in tumors as compared to free drug. This invasion-responsive delivery system will have two mechanisms: (1) a targeting mechanism that deposits anti- MIC drugs in the perivascular space of the tumor to block entry of MICs into blood vessels, and (2) an enhancing mechanism that releases the drug segment near MICs from dissolved nanoparticles to promote MIC-specific uptake of the drug. These mechanisms will be tested in the following three specific aims: Aim 1: Synthesize and characterize CP-drug conjugates. A hydrophobic drug, Sali, will be conjugated to CPs. The particle properties and in vivo systemic stability of the resulting conjugates will be examined. The working hypothesis is that attaching multiple copies of Sali will impart sufficient amphiphilicity to the CPs to induce nanoparticle self-assembly. The expected result is that the CP-Sali conjugate will form nanoparticles and improve the pharmacokinetics, anti-metastasis activity over free Sali. Otherwise, at least two strategies will be attempted to reinforce amphiphilicity and induce nanoparticle assembly: (1) adding a hydrophobic segment to the CP and (2) adding hydrophobic residues at the drug attachment segment of the CP. Aim 2: Study the relationship between the stability and metastasis-inhibiting activity of CP-drug nanoparticles. CP-Sali nanoparticles with varied intra- tumoral stabilities will be fabricated using different CPs (e.g., with varied charges and amphiphilicities). The metastasis-inhibiting effects of the CP-Sali nanoparticles will be evaluated and correlated to their intratumoral stabilities. The working hypotheses are (1) CP-Sali nanoparticle accumulation at the perivascular space will inhibit metastasis of MICs, and (2) the inhibiting effect of these nanoparticles will correlate with the intratumoral stability of the nanoparticles. The expected result is a single or group of CP-Sali conjugates with significant anti-metastasis activity. Aim 3: Study the enhancing effect of incorporating an invasion-associated enzyme cleavage site into CP-drug conjugates. An MMP2 cleavage site will be Figure 1. The workflow of the project incorporated into a CP carrier selected in SA2, and the MMP2-dependent cleavage, cellular uptake, cytotoxicity, and metastasis-inhibiting activity of CP(MMP2)-Sali conjugates will be evaluated. The underlying mechanism of this activity will also be investigated. The working hypothesis is that incorporating an MMP2-cleavage site into the CP sequence will improve the metastasis- inhibiting activity of CP-Sali conjugates by releasing the small Sali portion of the polymer following nanoparticle dissociation and enhancing Sali uptake to MICs. The expected result is a drug carrier system that successfully utilizes two characteristics of invasive MICs, their mobility (Aim 2) and protease activity (Aim 3). The proposed drug delivery system is innovative because it is (1) the first to utilize the mobility of metastatic cells; (2) the first to directly target metastatic cells; and (3) the first nanocarrier for anti-MIC drugs. Moreover, this proposal involves a significant paradigm shift in the hypothesis that the intratumoral drug delivery to target cells need not sacrifice carrier stability. The success of this project will significantly improve public health by decreasing the mortality caused by metastasis, and will highlight the importance of nanotechnology in improving cancer therapy.